NIDA INTERNATIONAL RESEARCH AND TRAINING PROGRAM SUPPORT SERVICES. 09/22/2018 - 09/21/2023. N01DA-18-1158.

The NIDA International Research and Training Support Program (IRTS) was initiated to promote the development of
collaborative international research through fellowships, technical consultation, and scientific information exchange.